Determining the Utilization, Cost, and Safety of Antipsychotics Among the Elderly with Dementia Post-Brexpiprazole Approval for Agitation in Alzheimer's Disease

Project Summary
The management of behavioral symptoms is a common and challenging aspect of care in older adults with
Alzheimer's disease and Alzheimer's disease-related dementias (AD/ADRD). Ensuring safe and effective
treatment is a top priority to improve patients' quality of life, alleviate caregiver burden, and support longer
community living. Practice guidelines recommend non-pharmacological interventions, such as caregiver
education and psychosocial interventions, as a first step. If symptoms persist, medications may be considered.
Antipsychotics have been commonly used off-label to manage behavioral symptoms in people with AD/ADRD,
despite none being FDA-approved for this indication until recently. In May 2023, brexpiprazole, initially
approved by the FDA in 2015 for treating schizophrenia and as an adjunctive therapy to antidepressants for
major depressive disorder, received supplemental approval for treating agitation associated with dementia due
to AD. The availability of this first FDA-approved pharmacological option may have several implications.
Brexpiprazole, the sole approved antipsychotic for treating agitation in individuals with AD in the US, is likely to
emerge as a highly favored pharmacological therapy, resulting in heightened utilization among people with
AD/ADRD, not limiting to AD. Furthermore, the FDA approval might impact clinical practice regarding the
prescription of antipsychotics for older adults across various specialties, probably making non-psychiatrist
providers more inclined to prescribe antipsychotics for this population. As a result, overall antipsychotic
prescriptions may potentially increase, reversing years of federal and state efforts aimed at reducing
widespread antipsychotic use among elderly individuals, especially in nursing homes. If brexpiprazole is likely
to replace older, commonly used, and inexpensive antipsychotics, the expenditure on antipsychotics in this
population may significantly rise, particularly in the absence of a commercially available generic version.
Importantly, like other antipsychotics, brexpiprazole still carries a “boxed warning” for the increased risk of
mortality and clinical trials were based on predominantly White (95%) participants. Furthermore, brexpiprazole
is not intended for `as needed' use but rather a daily maintenance strategy, with titration taking two weeks to
reach the recommended dose without an established optimal treatment duration, potentially leading to
increased long-term use. Hence, it is crucial to assess safety outcomes involving diverse populations through
an extended follow-up period in real-world settings. Our overarching objective is to determine the impact of the
first FDA-approved antipsychotic medication to treat agitation associated with AD with three specific aims
focusing on: i) utilization, ii) financial burden, and iii) long-term safety outcomes of antipsychotics among
Medicare beneficiaries with AD/ADRD in Texas. This state-level analysis will provide timely and informative
insights into antipsychotic use in the era of brexpiprazole's approval for stakeholders in Texas, and expected
outcomes will serve as the foundation for future national-level research endeavors.

Public health relevance
Project Narrative Brexpiprazole is the first and sole FDA-approved pharmacological option for treating agitation associated with Alzheimer’s disease (AD). This recent approval may lead to increased overall use of antipsychotics, changes in clinical practices, and a substantial impact on the financial burden and health outcomes associated with antipsychotic use among Medicare beneficiaries with dementia. Our project will determine the impact of the first FDA-approved antipsychotic medication to treat agitation associated with AD in terms of utilization, cost and safety outcomes of antipsychotics among Medicare beneficiaries with AD/ADRD in Texas, serving as the foundation for future national-level research endeavors.